Meeting support services for the Applied Research Program

This contract provides meeting support services for the Applied Research Program located within the NCI Division of Cancer Control and Population Sciences.